Role of Transglutaminase 2 in Synucleinopathies

Project Summary: α-Synuclein is a key pathogenic protein in Parkinson’s disease (PD) and Dementia with Lewy Bodies (DLB) based on genetic, neuropathologic, cell biologic and animal model studies. This intrinsically disordered protein can oligomerize, misfold, and form fibrils that propagate across neurons in the brain and accumulate in Lewy bodies and Lewy neurites. It is believed that the oligomeric forms of α-synuclein represent the toxic species, and these can nucleate monomers to perpetuate the pathologic process underlying the progressive nature of the disease. Thus, understanding the factors that trigger the initial steps of oligomerization is critical for designing disease modifying therapeutic strategies. A hitherto under-explored factor is molecular cross- linking of α-synuclein by transglutaminase 2 (TG2) between glutamine and lysine residues creating intermolecular isopeptide bonds that are highly resistant to proteolysis. Several lines of evidence indicate that TG2 cross-links α-synuclein leading to its aggregation in vitro, in cultured mammalian cells, in yeast cells, and in the brains of transgenic mice. We have found that the phenotype of α-synuclein transgenic mice is exacerbated by over-expressing TG2 and is mitigated by knocking it out. Studies in patients with α-synucleinopathy also corroborate the hypothesis that TG2 plays a pathogenetic role. TG2 expression is increased in the substantia nigra and cerebrospinal fluid of PD patients compared with control subjects, TG2 co-localizes with α-synuclein aggregates in stressed dopaminergic neurons in PD brains, and TG2-catalyzed cross-links co-localize with α-synuclein in Lewy bodies in PD and DLB affected brains. Despite this body of evidence, it remains unknown whether TG2-mediated cross-linking of α-synuclein promotes the propagation of these aggregates across the brain. We hypothesize that it does and propose to test this hypothesis through two specific aims: 1) Investigate if the presence of TG2 and its expression level influence the propagation of α-synuclein fibrils, and 2) Examine if the transglutaminase enzymatic activity of TG2 is responsible for this process. Knowledge gained from these studies will address a fundamental scientific question about the pathogenetic mechanism of TG2-mediated α-synuclein propagation and aid in developing targeted disease modifying therapeutic for synucleinopathies.

Public health relevance
Project Narrative: Parkinson’s disease and related disorders are associated with abnormal aggregation of the protein alpha-synuclein and the spread of these clumps in the brain. Identifying factors that start this process in its early stages can help us develop treatments to slow down disease progression. The goal of this project is to examine one of these factors.